Characterization of cAMP signaling microdomains in the human pathogen Trypanosoma cruzi

Abstract
Chagas disease (CD) is a leading cause of disability and premature death in the Americas. This vector-borne
infectious disease is caused by the protozoan parasite Trypanosoma cruzi. There is no vaccine to prevent CD
or satisfactory treatment for chronic patients. If untreated, the infection persists for a lifetime, causing serious
irreversible heart and gastrointestinal damage in one-third of the infected population, several years or even
decades after the initial contagion. Unfortunately, most affected individuals remain undiagnosed and untreated.
Understanding T. cruzi biology is crucial to develop alternative strategies to control Chagas disease.
T. cruzi life cycle involves a triatomine vector and a mammalian host. To survive microenvironmental stress,
the parasite differentiates into four main developmental stages. The molecular mechanisms driving these
transformations are highly unexplored. Cyclic AMP (cAMP) is a universal second messenger that regulates
diverse cellular functions, including cell differentiation. In mammalian cells cAMP signals are spatiotemporal
regulated by compartmentalization in subcellular microdomains to ensure specificity, duration, and intensity of
the signal, where phospodiesterases (PDEs) precisely regulate cAMP levels. Our laboratory recently discovered
two putative cAMP microdomains in T. cruzi: the flagellar distal domain (flagellar tip) and the contractile vacuole
complex (CVC). However, the specific role of cAMP in each one of these compartments remains unknown. Three
PDEs have been reported in these two structures: TcPDEB1, TcPDEB2 in the flagellum and TcPDEC2 in the
CVC. This study aims to characterize the flagellar tip and the CVC as signaling domains in T. cruzi. We
hypothesize that these two compartments are cAMP signaling microdomains involved in specific cellular
processes: cellular adhesion and metacyclogenesis (flagellar tip), and response to osmotic (CVC), where the
specificity of the signals is regulated by PDEs. To address this hypothesis, we propose to perform the functional
and structural characterization of cAMP microdomains in T. cruzi. To elucidate the specific function of each
microdomain, we will modulate the expression of flagellar and CVC PDEs by generation of overexpression and
knockout cell lines of the genes encoding these proteins. We will then evaluate cAMP content, cell adhesion,
metacyclogenesis, response to osmotic stress, host cell invasion, intracellular replication, and gene expression
profiles. For the structural characterization, we will use lipid raft markers for co-localization with cAMP signaling
proteins. This result will confirm the membrane assembly of cAMP signaling proteins in lipid rafts. We will also
use the fluorescent dye NR12S to monitor microdomain stability (membrane fluidity) in response to different
extracellular conditions. In addition, we will evaluate the interactome of specific proteins in each microdomain to
identify new signaling players present in each compartment. Results from this study will provide new insights
into the role of compartmentalized cAMP signals in T. cruzi, specifically during developmental transformations,
significantly contributing to understand environmental sensing in unicellular eukaryotes.

Public health relevance
Project Narrative Trypanosoma cruzi is the causative agent of Chagas disease, a vector-borne infectious disease that is endemic in the Americas, where it is considered a leading cause of disability and premature death, and for which there are no vaccines or satisfactory treatments available. In this study we are investigating essential signaling pathways that drive cell differentiation in response to the sudden environmental changes encountered by the parasite throughout its life cycle. Understanding how T. cruzi survives such changes is crucial to developing alternative approaches to diagnose and treat Chagas disease.